Polarity determinants in endolysosomal trafficking and proteostasis: Implications for Alzheimer's disease pathogenesis

Project Summary The vast majority of Alzheimer’s disease (AD) is sporadic, with aging being the biggest risk factor. Yet age-related changes within neurons that can drive the AD pathogenic process remain elusive. Intriguingly, there is an intricate link between the aging process and cell polarity. Dysregulation of polarity is observed in many cellular contexts during aging, such as increased permeability of epithelial barriers, defective asymmetric division of stem cells and increased frequency of cancer. However, whether brain aging and Alzheimer’s disease result from polarity dysregulation is unknown. Research in our laboratory has focused on the partitioning defective (Par) polarity proteins in neuronal development and degeneration. Interestingly, our recent studies point to a key role for Par3 in the pathogenesis of AD. AD is characterized by plaques composed of β-amyloid (Aβ), which is derived from amyloid precursor protein (APP) through cleavage by β- and γ-secretases. The rate-limiting step of Aβ generation is the convergence between APP and its β-secretase BACE1. We found Par3 expression is significantly reduced by middle-age, and loss of Par3 is common in human AD brains. In addition, Par3 depletion causes a significant increase in APP and BACE1 convergence. Unexpectedly, we found Aβ accumulates intracellularly in the absence of Par3. Further studies suggest this is caused by defective autophagosome clearance. Remarkably, accumulation of autophagosomes and other autophagic vacuoles is also characteristic of the AD brain. Thus, these exciting data have led to our hypothesis that loss of Par3 in the aging brain promotes AD progression by targeting both APP/BACE1 convergence and autophagy. Dysregulation of these processes will lead to intracellular Aβ accumulation, which is highly toxic to neurons. We will test our hypothesis through two aims. In Aim 1, we will elucidate the mechanism by which Par3 regulates APP and BACE1 convergence and intracellular Aβ accumulation. In Aim 2, we will examine the mechanism by which Par3 regulates autophagy and lysosome functions. We will use a combination of BiFC, optogenetic manipulation of Par protein activity, as well as in vivo analysis in forebrain- specific Par3 conditional knockout mice. Together, our proposed studies will establish the molecular mechanisms by which Par polarity proteins are involved in AD pathogenesis. The results will shed light on the mechanism of sporadic AD in which aging is the major risk factor and polarity dysregulation may be the common feature.

Public health relevance
Project Narrative Although aging is the biggest risk factor for Alzheimer’s disease (AD), there is a dearth of knowledge regarding age-related changes in neurons that can drive the AD pathogenic process. We recently found that in aging and AD neurons, there is a loss of a protein called Par3, which leads to increased generation and disrupted clearance of β-amyloid (Aβ) peptide, a key pathogenic agent in AD. Our proposed studies will further elucidate the signaling mechanisms of Par3 relevant to AD progression, which will shed light on the pathogenic mechanisms of AD and can potentially lead to novel therapeutic strategies.